1-13 ApoL1 Genotypes in Kidney Donors and Long-Term Outcomes in Kidney Transplant Recipients Clinical Center

PROJECT SUMMARY
APOL1 Long-term Kidney Transplantation Outcomes Network (APOLLO) Clinical Center
We submit this application in response to RFA-DK-22-506. The University of Miami, Miami Transplant Institute,
Jackson Memorial Hospital is the Clinical Center 11 which is a current member of the APOLLO Consortium. This
Consortium was established in 2017 to work seamlessly with the Association of Organ Procurement
Organizations (AOPO) to enroll participants in the largest observational study to date of kidney transplant
recipients and donors to evaluate APOL1 gene mutations in kidney donor as a risk factor for graft loss. Our
Clinical Center has been a leader and top enroller for eligible recipients and living kidney donors in the state of
Florida, Puerto Rico and 2 transplant centers in California. This has been achieved through a very close
collaboration between all site PIs and research coordinators. The following transplant centers are part of CC11:
participating as engaged centers are: The Miami Transplant Institute, Tampa General Hospital, Mayo Clinic
Jacksonville, the University of Florida; participating as non-engaged centers are: Advent Health Orlando Florida,
Memorial Healthcare System Broward Hospital Florida, Auxilio Mutuo Hospital in Puerto Rico, California Institute
of Renal Research and University of California, Irvine. In Phase 1 of APOLLO, we have successfully consented
241 kidney transplant recipients and 20 living donors, with DNA on hand in 220 recipients (91%) and 20 donors
(100%), across all centers. Our site has overseen the careful collection of clinical data from the electronic
medical record at our own site and subsites to complete the APOLLO Consortium Data Forms accurately and
entirely, with 97% to 100% of the data entry at various data points. In Phase 2, we will continue to obtain critical
follow-up data on all participants and ensure completion of data abstraction from electronic medical record, to
provide patient-level detail not available in databases maintained by United Network for Organ Sharing (UNOS)
and the Scientific Registry of Transplant Recipients (SRTR). We will ensure a urine albumin-to-creatinine ratio
is measured in all participants, at all sites, at a longitudinal follow-up time point of at least two years from original
enrollment in APOLLO Phase 1. The University of Miami, Miami Transplant Institute, will continue to collect
additional biospecimens for contribution to the biorepository as well as unstained biopsy slides as we have been
doing through Phase 1. We will work with the Scientific Data and Research Center (SDRC) to ensure return of
genotype results to all participants who desire this information. We will also continue to recruit living donors at
the Miami Transplant Institute. Continuation of the APOLLO Consortium will lead to important advances in our
understanding of APOL1 high-risk status and its influence on graft function as well as the biology of APOL1 gene
effects.

Public health relevance
PROJECT NARRATIVE CC11 APOLLO Clinical Center Network comprises of all major active kidney transplant centers in Florida and Puerto Rico, as well as the University of California-Irvine and California Institute of Renal Research. To support the APOLLO Consortium’s goal of enrolling all kidney transplant recipients across the United States who received a kidney from an African American donor, as well as all African American living donors, we will continue to leverage the infrastructure and collaboration we built in Phase 1 to ensure that we continue to obtain complete clinical data, urine albumin-to-creatinine ratio, and facilitate return of genetic test results to fulfill the mission of Phase 2. Additionally, we will also continue to enroll living kidney donors and obtain biospecimens for participants enrolled in Phase 1 at the Miami Transplant Institute, Jackson Memorial Hospital, according to the goals of the Consortium.